Imaging Epigenetic Mechanisms in the Lewy Body Dementias with [11C]Martinostat

Project Summary/Abstract Accumulating evidence suggests that epigenetic changes - functional modifications to the genome that do not change the DNA sequence and that provide a powerful mechanism by which environmental exposure can impact gene expression ? may contribute to dementia with Lewy bodies (DLB) and Parkinson disease (PD). Histone deacetylases (HDACs) are a family of epigenetic enzymes that regulate gene expression by chemically modifying chromatin, the network of proteins and DNA in chromosomal structure, in response to life experience and the environment. In DLB and PD at autopsy, histone acetylation is markedly dysregulated. However, it remains unclear whether histone acetylation-associated epigenetic changes accumulate with progression of disease including to dementia, for example reflecting the severity and topography of Lewy body pathology, nor whether HDAC changes relate to the accumulation of motor, cognitive, and behavioral impairments in these diseases. It is also unknown whether HDAC expression changes in life in DLB are distinct from those of Parkinson disease dementia (PDD). The recent development of [11C]Martinostat, the first radiotracer that labels HDACs in living humans, has enabled the antemortem assessment of HDAC levels and distribution in the human brain. [11C]Martinostat shows specific HDAC binding with low nanomolar affinity and is actively under study in several patient populations. The overall goals of this proposal are thus 1) to evaluate brain HDAC levels and regional distribution with [11C]Martinostat in well-characterized PD, PDD, and DLB subjects, contrasted with Alzheimer’s disease and age-matched normal control (NC) subjects, and 2) to relate regional [11C]Martinostat binding to Lewy body disease clinical features and amyloid burden. Subjects with DLB, PDD, cognitively normal PD, Alzheimer’s, and NC will undergo standardized neurological examination, detailed neuropsychological testing, combined [11C]Martinostat PET-MRI, and amyloid imaging with [11C]PiB PET. Building on preliminary [11C]Martinostat PET imaging and pathological data, we will test the following hypotheses: (1) The order of global brain HDAC expression will increase from AD to NC to cognitively normal PD to PDD to DLB; (2) Changes in regional HDAC expression detected with PET will correlate with the known topology of pathologic changes; (3) Cortical and striatal amyloid deposition will not qualitatively impact these results but will be associated with within- group reductions in regional HDAC expression; (4) HDAC expression in the putamen will correlate with the severity of motor impairment; asymmetry of nigral and striatal HDAC expression will correlate with asymmetry of motor impairment; (5) Global cortical and caudate HDAC levels will correlate with measures of cognitive impairment; (6) Posterior cortical HDAC expression will be associated with psychosis including visual hallucinations; (7) Differential HDAC expression in DLB and PDD will account for timing differences in the appearance of dementia relative to motor impairment in these diseases. Together, these efforts will shed light on the contribution of dysregulated epigenetic control of gene expression during life to PD, PDD, and DLB.

Public health relevance
Project Narrative Histone deacetylases (HDACs), a family of epigenetic enzymes that regulate gene expression by chemically modifying chromatin, are altered in Parkinson disease and dementia with Lewy bodies and may contribute to their development and their course. Employing [11C]Martinostat, the first radiotracer that labels HDACs in living humans, the overall goals of this proposal are (1) to evaluate brain HDAC levels and regional distribution with [11C]Martinostat in patients with Parkinson disease, Parkinson disease dementia, and dementia with Lewy bodies, compared to Alzheimer’s disease and normal control subjects; and (2) to determine how regional [11C]Martinostat binding relates to motor, cognitive, and behavioral features and to amyloid burden in these diseases. Together, these efforts will clarify the contribution of regional brain dysregulation of HDAC epigenetic control of gene expression during life to Parkinson disease, Parkinson disease dementia, and dementia with Lewy bodies and their clinical features.